Human Genetics and Clinical Translation

Project Summary
Adolescent idiopathic scoliosis (AIS) is a twisting condition of the spine and is the most common pediatric
musculoskeletal disorder, affecting 3% of children worldwide. Children with AIS risk severe disfigurement, back
pain, and physiologic dysfunction later in life, and are treated symptomatically rather than preventively because
the underlying etiology is unknown. Girls requiring treatment for AIS outnumber boys by more than five-fold. Our
overall purpose is to understand the biologic causes of AIS as a means to early diagnosis, prevention and non-
invasive biologic treatment. With support from this P01 in the previous award period we substantially increased the
number of validatedAIS susceptibility loci by large-scale multi-ethnic GWAS meta-analysis. Together with the other projects
in the program we also established that the cartilage extracellular matrix (ECM) is a functional tissue in AIS. We
subsequently discovered that nonsynonymous variants in genes encoding ECM components COL11A1 and MMP14 are
associated with AIS. Together with genomics Project 3 we uncovered evidence of sex-biased PAX1-COL11A1
expression. In parallel, whole genome sequencing in families identified candidate mutations in AIS families that zebrafish
Project 2 is engineering into orthologous zebrafish genes. Here we propose to drive these discoveries forward to develop
mechanistic understanding of AIS pathogenesis. In one aim of the project, we will evaluate the consequences of
Col11a1 loss from chondrogenic lineages by generating Col11a1fl/fl /ATC Cre lines, inducing cre recombination
at embryologic and at early postnatal timepoints. Mutant offspring and their littermates will be evaluated
phenotypically and morphologically, by imaging, quantitative immunohistochemistry and mechanical strength
testing of growth plate and intervertebral disc (IVD) cartilages. With Project 3-Genomics we will also perform
single cell RNAseq coupled with ATAC-seq in IVD to define the role of Col11a1 at cellular levels. To characterize
the role of Mmp14 in mouse spine, we will characterize its spatio-temporal expression, and its cell-specific role
in spine development using MT1-MMPlacZ/+ knockin lines. In a second aim, we will continue reverse engineering
together with Project 2-Zebrafish and Project 3-Genomics to characterize the molecular and functional
consequences of spine deformity-associated mutations in vertebrate models. In a reciprocal fashion we will
cross-reference new scoliosis candidate alleles identified in Project 2-Zebrafish or Project 3-Genomics with
those identified in our human cohorts. In a third aim we will discover novel high-risk scoliosis-associated variants
by genome sequencing extended families and a unique cohort of AIS treatment non-responders. We will also
identify new spine deformity mutants from our highly productive ENU-induced genetic screen in mice. Building
on the momentum of our previous discoveries, we will synergize with Zebrafish Project 2 and Genomics
Project 3 in further defining pathways and developmental mechanisms of spine development and deformity. Our
collaborative will also continue to define the genetic architecture of AIS and yield tools that will enable better
diagnosis, interventions, and preventions.